Delineating the contribution of muscle wasting to tumor progression

ABSTRACT
Skeletal muscle wasting affects up to 80% of patients with advanced cancer and directly impacts surgical
prognosis, chemotherapeutic response, morbidity, mortality, and quality of life. While considerable effort has
gone into understanding how tumors (and the host response to tumors) contribute to the etiology of cancer
cachexia, relatively little is known about how the cachectic state in turn influences tumor dynamics. Our long-
term goal is to develop a better understanding of reciprocal tumor-host interactions to approach therapeutic
development more holistically in cancer patients. We present preliminary data highlighting the role of muscle
wasting with respect to tumor progression. First, we show that mice genetically engineered to resist muscle
wasting exhibit enhanced survival and slower tumor growth compared to matched control mice subjected to the
same tumor transplantation protocol. Second, preliminary analyses of tumors isolated from these mice point to
significant differences in cell type composition and gene expression as a function of muscle wasting. Third, we
observe a divergent/unique secretome associated with ongoing myofiber atrophy. This proposal builds on these
exciting findings and will address the central hypothesis that skeletal muscle wasting actively promotes tumor
progression. In this proposal we will 1) detail tumor progression in the presence/absence of muscle wasting and
determine if wasting prevention and intervention is sufficient to augment tumor growth, and 2) interrogate the
skeletal muscle secretome to better understand the fate, composition, and function of catabolic muscle
breakdown products. Together, we anticipate this work being a significant and innovative step towards better
understanding the dynamic and complex relationship between tumors and host tissues, such as skeletal muscle.

Public health relevance
PUBLIC HEALTH RELEVANCE The proposed studies will use cell/molecular biology, biochemistry, and mouse modeling to better understand how muscle wasting contributes to tumor progression. The long-term goal of our group is to leverage our understanding of complex tumor-host interactions to better treat and support patients with cancer.